Integrated Clinical Neuroscience Training for Translational Research

The Integrated Clinical Neuroscience (ICN) Training Program, operating within the Clinical Psychology and
interdisciplinary Neuroscience programs at Florida State University for the past 9 years, seeks to train the next
generation of investigators to become leaders in translational research and make major advances in several
areas of psychopathology characterized by dysregulated behaviors including eating disorders, depression,
anxiety disorders, suicidality, post-traumatic stress disorder, and substance use disorders. These problems are
associated with significant psychological and medical morbidity, elevated mortality, and high economic burden.
This underscores the need for research that translates the neural mechanisms underlying normal and
abnormal behavior in animals into clinical studies of the causes and treatment of mental disorders. However,
segregation of doctoral training in Clinical Psychology and Neuroscience, with separate courses, lab
experiences, and exposure to outside speakers, impedes new scientists’ preparation to undertake translational
approaches in their own research. The ICN Training Program was designed to break down these barriers.
Here, we seek continued funding to provide integrated instruction, research experience, and mentorship to 4
predoctoral ICN trainees earning PhDs in Clinical Psychology and Neuroscience through 1) cross-area
courses, 2) cross-area lab rotations, 3) a Special Speaker Series in which trainees present their research to
invited scholars conducting translational science, and these scholars present their work to trainees, our
participating Departments, and the community, 4) presentation of research at conferences and in published
papers, and 5) instruction in grant writing, data science, and cross-area instruction in the responsible conduct
of research. Predoctoral trainees apply for the ICN Training Program by describing research they plan to
conduct in collaboration with their primary advisor and cross-area mentor, classes they will complete, and how
this cross-area exposure will contribute to their career development as translational scientists. Students are
typically appointed for two years beginning in their 3rd to 4th year to ensure selection of the most promising
trainees who have completed basic program requirements and established research interests that can be
extended by a cross-area lab rotation. Our training model has supported a total of 19 trainees. Among the 13
ICN trainees who have completed the Ph.D., 92% have continued in research careers (with 4 currently in
tenure-track positions) and 77% have received highly competitive fellowships and independent research
grants. Training faculty, selected for their cross-area connections in research addressing dysregulated
behaviors, continue to excel in securing grant funding and training students for research careers with strong
publication records. Continuation of the ICN Training Grant for an additional 5 years will build upon our
accomplishments and ensure that a third cohort of Ph.D. students is ideally positioned to initiate cutting-edge
translational research to address mental disorders characterized by dysregulated behaviors.

Public health relevance
Mental illness characterized by dysregulated behaviors contribute to emotional and physical suffering and are associated with high healthcare costs and increased risk of death to the self and others. The proposed training program will train the next generation of investigators pursuing translational research to reveal the underlying mechanisms contributing to mental illness and reduce disorder-related suffering, economic burden, and mortality through identifying novel targets for prevention and treatment.